Empowering Cardiovascular Health in Custodial Grandparents (ECG)

PROJECT SUMMARY
There has been a steady increase in grandparent caregiving in the US. This acceleration is due to recent
trends in domestic violence, parents’ incarceration, parents’ death due to the COVID-19 pandemic, and opioid
overuse that increase familial instability and leave more grandchildren to be cared for by custodial
grandparents. These grandparent caregivers face ongoing stressors as they navigate legal custody
arrangements, cope with loss of their own child(ren), or face social isolation. A higher prevalence in an array of
social determinants of health often put them at higher risk for cardiovascular disease (CVD): belonging to a
racial/ethnic minority, living below the poverty line, living in single-caregiver households, and having lower
levels of educational attainment. Additionally, custodial grandparents appear to have higher rates of adverse
childhood experiences, another known risk for CVD. This unique mixture of stressors manifests in custodial
grandparents’ health, where they are at higher risk for CVD compared to their non-caregiving peers. However,
there is a dearth of intervention addressing custodial grandparents’ CVD risk. To address this gap and optimize
healthy aging and cardiovascular health among this growing at-risk population, we will implement a virtually
delivered, evidence-based CVD risk reduction intervention - The Rural Caregiver Heart Health Education
[RICHH] Intervention.
The RICHH intervention was originally targeted for adult caregivers of adult family members with a chronic
illness, and has not been tested in the context of custodial grandparents’ CVD risk. We propose a 3-year
planning project to determine the feasibility, acceptability, and initial effect of the RICHH intervention conducted
with custodial grandparents. We will employ a mixed method design and conduct a 2-arm randomized
controlled trial with 70 custodial grandparents in Oregon. The specific aims are: 1) modify the RICHH
intervention to target custodial grandparents from a variety of backgrounds; 2) employ the re-designed
intervention and assess its feasibility and acceptability; and 3) evaluate and refine the RICHH protocol among
our team members and explore the initial effect of the intervention based on measures of CVD risk, self-
management behaviors, and depressive symptoms at 4-months and at 6-months, compared to baseline.
Expected outcomes are to complete the sufficient and scientifically necessary groundwork to support a future
clinical trial that will test the effectiveness of the RICHH intervention with a longer follow-up and increased
inclusivity of participants from marginalized populations, with the objectives of: a) preventing CVD-related
morbidity and mortality and overall physical decline, b) improving psychological well-being in these
grandparents, and c) fostering a more heart-healthy environment in grandfamilies.

Public health relevance
PROJECT NARRATIVE A steady increase in the number of grandparent caregivers, accelerated by recent trends such as children orphaned by COVID-19 or the opioid crisis, magnifies the importance of addressing cardiovascular disease risk in that group which is already at high risk. To date there has been little effort to address the specific heart health needs of this important population. In this study we will tailor an existing intervention protocol and test its feasibility, acceptability, and initial effect with grandparent caregivers, in preparation for a larger scale clinical trial.